Opening Dental and Oral Research Summers (DORS) to Scientific Careers throughout Oregon

SUMMARY:
The goal of the Dental and Oral Research Summers (DORS) program is to create pathways to careers in dental,
oral, and craniofacial research by opening doors to undergraduate scholars particularly from rural and under-
represented communities within Oregon by providing summer research internships. Our dental school has
recently received an NIH/NIDCR T90 training grant and has the infrastructure to build upon for this current R25
application. At the core of both training opportunities are the leading experts in oral microbiology, dental
materials, and tissue regeneration. We have expanded the breadth of opportunities by creating a second
research track to include community dentistry and nutrition. We have established an internship in Southwestern
Oregon for learners who would not otherwise be available to spend a summer in Portland due to the distance.
Summer interns will be welcomed into these rich laboratory and community environments. We have partnered
with the state of Oregon's community leaders in rural health and in diversity to attract a robust cohort of applicants
representing under-represented minorities and nontraditional learners. We have identified peer mentors from our
current DMD Student Research Group to provide direction during the summer. And, we have a strong Leadership
and Advisory Team who are themselves diverse and passionate about mentoring undergraduate research. While
several excellent programs already exist for internships in biomedical research at OHSU to recruit
undergraduates, OHSU currently lacks a mechanism to recruit learners specifically interested in dental, oral and
craniofacial research. The DORS will establish partnerships with existing biomedical training programs at OHSU
and Portland State University and build our cohort in dental, oral and craniofacial research. Success of this
application will lead to increasing the number of dental scientists in the state of Oregon and the number of diverse
dental scientists by providing them a strong summer research program early in their careers.

Public health relevance
NARRATIVE: SOD-OHSU R25 Summer Research Education Experience Application (PAR-21-168) To open Dentistry and Oral Research Summers (DORS) in Oregon The overall goal of the SOD R25 Summer Research Experience is to open doors for undergraduate scholars in pursuing a career in dental, oral, and craniofacial research and to increase representation within our research community from rural Oregon and from under-represented communities within Oregon. By presenting the opportunities and rewards that lie in being a research scientist and addressing barriers, we will transform learners who are interested in summer research to oral health researchers at all levels.